Endometrial epithelial stem cells and cancer

Uterine cancer is the 4th most frequent malignancy and the 6th cause of cancer-related deaths in women in the
US. While the incidence and mortality rates of some cancers, such as lung and colorectal cancers, are declining,
they are both increasing for cancers of the uterine corpus. Recent extensive integrated genomic analyses of
endometrial carcinomas have provided important insights into the repertoire of molecular aberrations
characteristic of these malignancies. They have also identified four major molecular subtypes of endometrial
carcinoma, characterized by distinct genetic alterations and clinical behavior. However, utilization of this
information is compromised because the cell(s) of origin have not been determined. By analogy with stem cells
in other organs and tissues, aberrations in mechanisms governing endometrial epithelial stem cells may lead to
a number of pathological conditions, including cancer. Unfortunately, the identity and location of endometrial
stem cells remains insufficiently elucidated.
A number of recent studies have suggested location of stem cells either in the glandular or luminal
compartments of the mouse endometrial epithelium. In humans, such cells are commonly thought to be located
in the basalis segment of the endometrial glands. However, according to a recent single cell transcriptome study
of secretory phase human endometrium, cells showing characteristics of stem/progenitor cells are located in the
upper region of the functionalis. Other studies have suggested that endometrial epithelium can be regenerated
by stem cells of stromal/mesenchymal or bone marrow cell origin.
Our studies performed in mice conditionally expressing fluorescent reporters in PAX8+ cells support the
hypothesis that stem cells involved in the homeostasis of endometrial epithelium are located in the epithelium
proper. By using single cell transcriptome analysis, we have identified TROP2 (encoded by Tacstd2) and FOXA2
as reliable markers of luminal and glandular compartments, respectively. Our lineage trajectory predictions,
organoid formation and lineage tracing experiments suggest that both luminal and glandular epithelium contain
stem/progenitor cells. TROP2 and FOXA2 are also differentially expressed in human endometrial epithelium.
Based on previous findings and our preliminary results we hypothesize that endometrial epithelium contains two
pools of resident stem/progenitor cells, which may have different propensities for malignant transformation,
thereby leading to clinically distinct neoplasms. To test this hypothesis, we will establish cell lineage hierarchy of
the mouse endometrial epithelium, test susceptibility of the mouse glandular and luminal epithelium to malignant
transformation associated with alterations common for serous and endometrioid carcinomas, and establish the
relevance of mouse model findings to human biology.

Public health relevance
Project Narrative We anticipate our work will offer in depth information about molecular mechanisms governing endometrial epithelium homeostasis. Our work will dramatically improve our understanding of endometrial carcinoma pathogenesis and lay the essential foundation for translational studies, such as identification of unique biomarkers and therapeutic targets based on stratification of endometrial carcinoma according to their cell of origin and causative genetic alterations. Our studies will also provide a solid basis for future studies of other critical issues of reproductive biology, such as infertility and endometriosis.